Medical Scientist Research Service Award

Use continuation pages as needed Start with Principal Investigator. List all other key personnel in alphabetical Name Organization James L. Salzer, M.D. Ph.D. NYU School Mark R. Philips, M.D. " Michael J. Garabedian, Ph.D. " Gert Kreibich, Ph.D. " David Ron, M.D. " Alexander F. Schier, Ph.D. " Naoko Tanese, Ph.D. Arlene Kohler, B.A. " Disclosure Permission Statement. Applicable to SBIR/STTR Only. See + PHS 398 (Rev. 05/01) to provide the required information in the format shown below. order, last name first. Role on